Reducing Parenting Stress to Facilitate Justice-Involved Youth's Treatment Engagement

PROJECT SUMMARY / ABSTRACT
In response to PA-20-272, this supplement study proposes to evaluate the feasibility and acceptability of a
linguistically adapted mobile health (mHealth) intervention (RAISE) for Spanish speaking caregivers of legally
involved youth. The proposed research supports Goals 2 and 5 of the 2022-2066 NIDA Strategic Plan by
bolstering family support for adolescents using substances and translating research on mindfulness-based stress
reduction into an innovative mHealth application. Latinx youth are overrepresented in the juvenile legal system,
making up 22% of youth in residential facilities (including residential treatment centers, detention centers, training
schools, and juvenile jails and prisons).1 Although inequities in Latinx youth incarceration have improved over
the past decade, they remain 28% more likely to be detained or committed in juvenile facilities compared to their
white peers.2 Monolingual Spanish speaking caregivers face additional challenges navigating the juvenile legal
system due to the lack of linguistically accessible resources in the community and within the juvenile court
system. The RAISE app, which was developed under the Parent K23, is a parenting stress reduction intervention
mHealth app that was co-designed with English speaking caregivers of legally involved youth using participatory
informatics. RAISE is currently only available in English, however the co-design team included 1 bilingual
(English, Spanish) Latinx caregiver and the app was tested by 6 additional users in an open trial, 25% of whom
identified as Latinx. The inaccessibility of RAISE in languages other than English has been raised as a concern
by our collaborating systems partners due to the high number of monolingual Spanish speaking caregivers in
Northern California, where the work is primarily being conducted. Additionally, the Institutional Review Board at
the University of California, San Francisco where the PI is located commented that there is not a clear scientific
rationale for exclusion of caregivers based on English language proficiency, particularly given ethnoracial
inequities in representation in the legal system. Latinx individuals in the U.S. are interested in using mHealth
interventions3 and Latinx smartphone users are more likely than whites to use a health app4, however most
studies of mHealth interventions do not include or have low rates of Latinx participation. The current supplement
would allow for content translation to make the RAISE app available to Spanish speaking caregivers who could
benefit and provide crucial information about the equitable and ethical use of digital health interventions with
Spanish speaking caregivers of legally involved youth. The proposed research will also expand Dr. Folk's work
on improving behavioral health outcomes for marginalized youth and their families by advancing the linguistic
and cultural accessibility of her work. Findings will be used as the foundation for a larger R01 hybrid design
clinical trial testing the efficacy of RAISE in both English and Spanish, propelling a federally funded program of
research designed to increase substance use treatment engagement and improve behavioral health outcomes
for legally involved youth and families.

Public health relevance
PROJECT NARRATIVE The proposed K23 supplement aims to evaluate the feasibility and acceptability of a linguistically adapted mobile health parenting stress intervention for caregivers of legally youth, a population with high rates of substance use and low rates of treatment engagement. Findings will contribute to the public health and juvenile legal fields by providing crucial information about the equitable and ethical use of mobile health interventions with Spanish speaking caregivers of legally involved youth. The proposed work will also expand the investigator's capacities as an independent health services investigator striving to improve behavioral health outcomes for marginalized youth and families by advancing the linguistic and cultural accessibility of her work.